BioPROTAC-Mediated Degradation of HIV-1 Rev

Project Summary
In 2023, approximately 40 million people globally, including 1.2 million Americans, were living with HIV-
1, which causes acquired immunodeficiency syndrome (AIDS). The current standard care involves daily
small-molecule antiviral drugs, which reduce viral load and the probability of transmission but do not cure
the infection. Adherence to treatment is challenging due to side effects and complex regimens, leading to
drug resistance and treatment failure. One way to combat the emergence of drug resistance is to develop
novel anti-HIV-1 agents against alternative targets. Since small-molecule anti-HIV-1 drugs are generally
limited to targeting viral enzymes that possess hydrophobic binding pockets, we propose to target critical,
non-enzymatic HIV-1 proteins with nanobodies. In this project, we aim to develop protein-based proteolysis
targeting chimeras (bioPROTACs) to degrade HIV-1 Rev protein, which is critical for the HIV-1 lifecycle
but does not contain any hydrophobic pocket for small molecules to bind. This approach is enabled by the
recent development of a powerful intracellular protein delivery platform, membrane translocation domains
(MTDs), in one of our laboratories. Specific Aim 1 is to generate and biochemically characterize a small
family of Rev-degrading bioPROTACs by recombinantly fusing MTD4 (one of the most active MTDs), a
previously reported Rev-binding nanobody (Nb190), and several commonly used E3 ubiquitin ligases.
Specific Aim 2 is to test and validate the bioPROTACs from Aim 1 for the targeted degradation of HIV-1
Rev in live cells. The development of a bioPROTAC strategy targeting Rev or other essential viral proteins
for HIV-1 therapy presents several compelling advantages in the fight against HIV. This approach opens
a novel pathway for targeting viral proteins that are difficult to inhibit using traditional small molecules. By
leveraging PROTACs, which harness the cell’s own machinery to degrade the target protein, the likelihood
of resistance arising from viral escape mutants—common in conventional inhibition-based therapies—is
significantly reduced. PROTACs can also be designed for high specificity, minimizing off-target effects and
toxicities often associated with small-molecule drugs. Furthermore, combining PROTACs with traditional
antiretroviral therapy could create a multifaceted strategy, enhancing long-term viral suppression.

Public health relevance
Project Narrative Resistance to current anti-HIV-1 therapies is a significant and growing concern. This project aims to develop a novel anti-HV-1 therapy by generating cell-permeable fusion proteins that specifically degrade (and eliminate) Rev, a protein critical for the lifecycle of HIV-1 but not amenable to conventional small-molecule drug approaches.